Core A: Administrative Core

ABSTRACT – Core A, Administrative Core
The Administrative Core, Core A, provides overall scientific, organizational, administrative, fiscal, and
regulatory management of this P01, “Clinical Care Gaps and Unmet Needs in Adolescent and Young Adult
(AYA) Cancer Survivors.” Organizationally, the core will be led by an Executive Committee (EC) consisting of
the four multiple Principal Investigators, Project 2 leader Dr. Erin Hahn, and Core B leader Dr. Charles
Quesenberry; thus, all project and core leaders are represented on the EC. The EC will be responsible for
overseeing projects, shared resources, institutional budgets, subcontracts, and Institutional Review Board
submissions and modifications. It will oversee allocation of resources to align with the needs of individual
projects and cores as well as the P01 overall. The EC will also be responsible for soliciting and incorporating
insights from an External Advisory Board (EAB) that includes six individuals with substantial expertise in the
areas of interest for this P01. The EC will interact with the Steering Committee (SC), including all project and
core leadership and key co-investigators, including Ms. Mallory Casperson, an AYA cancer survivor and CEO
and founder of Lacuna Loft, an online AYA patient support and advocacy group. The SC will be responsible
for overall scientific strategies and decisions, and ensuring synergy and dissemination of best practices among
all P01 components. The SC is also central in communicating about P01 activities with the external research
and patient communities. Core A will have three standing committees: 1) Population and Data Resources,
working closely with the Biostatistics and Survey Shared Resource Cores (Cores B and C, respectively); 2)
Publications and Ancillary Studies; and 3) Patient Engagement. Core A Specific Aims are to:
1. Provide overall scientific, organizational, administrative, fiscal, and regulatory management of this P01;
2. Implement methods for and facilitate seamless communication among all components of the P01; identify
efficiencies, common interests or approaches; and enhance synergy among program components;
3. Identify and incorporate opportunities to enhance the relevance and impact of this P01, through a patient
engagement committee, through the EAB, and through other informal interchanges with the clinical,
patient, and scientific communities.
Core A will provide oversight of all P01 activities. EC and SC members have experience in areas
critical to this program of research, including AYA cancer survivorship; patient engagement in research;
healthcare data acquisition and analysis; and directing and managing national multisite research consortia.
These experiences guide the organizational structure under which the P01 will operate, which emphasizes
integration of projects and shared resource cores to enhance synergy, incorporates the views of AYA cancer
survivors, and interacts with an outstanding EAB. This Core will ensure that the promise described in the P01
project components reach their maximal potential.